Pittsburgh Liver Research Center

The Pittsburgh Liver Research Center or PLRC was founded in 2016 through intramural support from the
institution and due to a high interest in bringing together scientists and physicians with the common goal of
addressing an increasing burden of liver disease. The long-term objective of PLRC has been to promote
impactful science in understanding the cellular and molecular basis of hepatobiliary injury and repair, with an
eventual goal of improving outcomes in liver diseases in both adult and pediatric populations. Since its inception
in 2016, and NIDDK-funding in 2019, the PLRC has brought together a constituency of individuals with strong
track records in basic and translational liver research. The PLRC is thus a multidisciplinary center that builds on
the historic strengths of the University of Pittsburgh Medical Center (UPMC), a leader in the delivery of innovative
and cutting-edge clinical care, and the University of Pittsburgh (Pitt), a leader in research, discovery, education,
and innovation. Serving as a point of convergence for timely research in liver health and disease, the PLRC
promotes interactions, collaborations and intellectual exchanges between the researchers from various
disciplines as well as between researchers and clinicians to improve the comprehension of complex hepatic
diseases for improved understanding of the underlying mechanisms. The PLRC provides an integrated platform
to enhance, enrich, and synergize scientific interactions among investigators working in the field of liver
pathobiology who currently reside in diverse departments and institutions at the UPMC and Pitt. This is
accomplished by enabling and fostering multi-, trans- & inter-disciplinary collaborations, providing an optimum
infrastructure for liver research in three key areas, which also are the three Scientific Interest Groups of the
PLRC, i.e. Injury, Repair and Transformation. PLRC is currently composed of 79 all members that consist of 46
full members that form the research base, 4 Pilot & Feasibility members, 9 Leader members and 20 Associate
members. PLRC is administered by the Administrative Core, which enables a seamless integration of various
functions of the PLRC through optimal organization of the PLRC. The Admin Core has also formed alliances with
other centers and institutes within and outside Pitt to provide additional resources and opportunities to the PLRC
members. PLRC offers 4 state-of-the-art Biomedical Research Cores- the Advanced Cell and Tissue Imaging
Core, the Clinical Biospecimen Repository and Processing Core, the Genomics and Systems Biology Core and
the Human Synthetic Liver Biology Core. PLRC is highly invested in next-generation of liver-focused
investigators by providing research funding, mentoring and access to research infrastructure to help promote
their independent career in academic medicine. Eventually, PLRC serves as a platform for continued education
while promoting scientific exchange and collaborations among members to eventually bridge the void between
basic research and clinical practice. Thus, the PLRC serves its multi-faceted mission of discerning complex
tribulations in hepatic health and disease by enabling innovative, collaborative multi-disciplinary research in the
highly relevant area of cellular and molecular basis of hepatobiliary injury and repair. We firmly believe that
discerning fundamental cellular and molecular processes of common liver pathologies that remain major unmet
clinical needs through team or individual investigator led research, supported by optimal infrastructure, resources
and enrichment is critical for successful translation and impact.

Public health relevance
Elucidating the cellular and molecular underpinnings of liver injury repair may yield improved cures for liver diseases, which remain a global and national health burden. Pittsburgh Liver Research Center was created to address this issue by providing a group of invested established and early stage investigators an opportunity to interact and collaborate as well as have access to the most advanced scientific core facilities. We believe that PLRC will have a major impact on treatment of liver disease patients by enabling innovative discoveries.